Mechanisms of repeated opioid use dependent remodeling in respiratory control

ABSTRACT
Alzheimer’s disease (AD) is estimated to afflict nearly 13 million Americans by 2050. As no current therapies
have been proven to reverse or stop the progression of the disease, AD is on track to become a greater burden
to the American healthcare system. This is further compounded by a lack of understanding into the factors
influencing the onset and progression of AD. While there is a growing recognition between the importance of
opioid receptor-based neuromodulation and AD-related pathogenesis, the impact that opioid use has on the
progression of AD is poorly understood. The ongoing opioid epidemic and continued prescription of opioids
among individuals with AD and related dementia (ADRD) may be significant factors that influence the trajectory
of AD progression later in life. However, a significant knowledge gap exists in understanding the unintended
consequences of repeat opioid use (ROU) on ADRD-related pathogenesis. The parent grant aims (1) to
understand the consequences of ROU on the control of breathing. This supplement builds on this foundation
with the objective to understand how opioid modulation impacts the pathogenesis and behavioral phenotypes
related to AD. We hypothesize that ROU exacerbates amyloid β burden and neurocognitive deficits related to
AD while the severity of the AD phenotype may be ameliorated by targeted inhibition of the mu opioid receptor.
To test this, we propose two aims that: (1) examines how repeat opioid use influences histological changes
associated with AD and cognitive performance in a mouse model of AD; and (2) determines how the severity of
AD-related phenotypes may be impacted by inhibition of endogenous MOR activity. Therefore, we will provide
greater resolution in understanding how targeting opioid modulation may influence the pathogenesis of ADRD.
These advancements may lead to novel efficacious preventive strategies to address ADRD and monitor the
progression of ADRD.

Public health relevance
PROJECT NARRATIVE Opioid use may be an unrecognized modifiable-risk factor for Alzheimer’s Disease. Thus, the ongoing opioid epidemic may have a substantial impact on the future prevalence of AD. This project aims to investigate how exogenous opioid and intrinsic opioid modulation impacts amyloidgenesis.